Training Program in Environmental Toxicology

Abstract
Environmental agents play a significant role in the development of human
disease. The identification of such toxicants and understanding their causal role
in disease can rapidly be used in risk assessment and management and holds
enormous promise in terms of preventive, therapeutic and clinical scenarios.
This application requests funds to continue NYU’s training program in human
health assessment and environmental and molecular toxicology. Specifically, we
request funding to support the stipends and tuition of 6 predoctoral and 3
postdoctoral trainees annually in the NYU Graduate Program in Environmental
Health Sciences. The training will address a broad spectrum of problems in
environmental health, from the causative molecular mechanisms of cancer,
cardiopulmonary diseases, and other environmentally-related disorders to the
development of animal models which may be used for predicting the adverse
effects of environmental agents on human health. The major strength of the
proposed toxicology training program is the outstanding quality and
interdisciplinary diversity of the training faculty, which will provide the predoctoral
trainees an excellent opportunity to conduct environmental and molecular
toxicology research in laboratories of investigators with outstanding international
reputations. The mission of this training program is to develop creative and
independent research scientists who can address the problems presented by
complex exposures to environmental pollutants in combination with the stresses
of a rapidly changing physical environment.

Public health relevance
Narrative This application requests continued support of NYU’s training program in environmental and molecular toxicology by supporting the annual stipends and tuition of 6 predoctoral and 3 postdoctoral trainees in Environmental Health Sciences. The mission of this training program is the development of creative and independent research scientists who can address the problems presented by complex exposures to environmental pollutants.